The Role of IGFBP-3 in Mitochondrial Homeostasis in the Corneal Epithelium

PROJECT SUMMARY
Dry eye disease (DED) is one of the most common visual conditions that increases with age and
disproportionally affects women. DED disrupts vision, is often painful, and negatively impacts the quality of life
for those affected. Current treatments have limited efficacy and there is no cure.
An increase in tear osmolarity is a central feature of DED. Hyperosmolarity triggers mitochondrial dysfunction
that ultimately results in caspase release and subsequent apoptosis. Work in our laboratory has found that the
insulin-like growth factor binding protein-3 (IGFBP-3) is secreted from corneal epithelial cells (CEC). Secretion
of IGFBP-3 is downregulated in response to hyperosmolarity. Of high importance to this proposal, the addition
of recombinant IGFBP-3 to CECs cultured in hyperosmolar conditions blocks the hyperosmolar-induced
decrease in mitochondrial respiration. We further provide novel data that suggests that IGFBP-3 may mediate
autophagic flux in CECs during stress. The purpose of this proposal is to investigate a potential role for
IGFBP-3 in mediating mitochondrial metabolism, mitophagy, and macroautophagy (autophagy) in DED.
Based on these collective findings, we propose the central hypothesis that IGFBP-3 mediates cellular
homeostasis in CECs during hyperosmolar stress through control of mitochondrial metabolism and
autophagic mechanism(s). This hypothesis will be tested using a combination of in vitro cell cultures and in
vivo animal studies to establish the relationship between IGFBP-3, mitochondrial homeostasis and metabolism.
In Aim 1, we will focus on the metabolic effects of IGFBP-3 in CECs exposed to varying levels of hyperosmolar
stress in vitro and characterize expression of IGFBP-3 in a desiccating stress mouse model in vivo. In Aim 2,
we will focus on the role of IGFBP-3 in mitophagy and autophagy in CECs exposed to hyperosmolar culture in
vitro and in vivo using CEC lines and mice that stably express the autophagosome marker, GFP-LC3, and the
pH sensitive fluorophore, mt-Keima.
The proposed studies will be the first to explore a pathophysiological role for IGFBP-3 in mitochondrial
respiration, homeostasis, mitophagy and autophagy in CECs exposed to hyperosmolar stress.
Elucidating the role of IGFBP-3 in DED may lead to the development of novel therapies to treat and mitigate
disease. The outstanding research environment at UT Southwestern combined with the collective
expertise from my multidisciplinary mentorship team will provide exceptional training and a solid
platform to build upon as a future physician-scientist in Ophthalmology and Vision Science.

Public health relevance
NARRATIVE Dry eye disease (DED) is a painful and chronic condition, affects up to 50% of the adult population, and has no adequate treatments or cure. Since the prevalence of DED increases with age and the number of US adults aged 65 years and above continues to grow, the emotional, physical, and financial burden of the disease is also increasing. This proposal seeks to determine the role of the insulin-like binding protein (IGFBP-3) in maintaining corneal epithelial cell homeostasis during DED, with a long term goal of developing novel targeted therapies that will protect the cornea and preserve vision.